Posttranslational modifications of glucocorticoid receptor associated with drug-resistance in prostate cancer

PROJECT SUMMARY (ABSTRACT)
An evolving concept that contributes to our understanding of resistance to androgen deprivation therapy
(ADT) or androgen receptor (AR) antagonists in advanced prostate cancer (PCa) is the ability of cells to
evade AR blockade and turn on compensatory hormone receptor signaling for survival. Preclinical and
clinical studies by us and others have demonstrated that induction of glucocorticoid receptor (GR)
expression confers resistance to AR-targeted therapy. Elegant studies by others in the hormone
receptors field have shown that posttranslational modifications (PTM) on nuclear hormone receptors can
amplify or alter their canonical activity to favor cancer cell survival or drug resistance. One such PTM is,
phosphorylation. We published that pan-AKT inhibition blocks GR induction/activity and overcomes GR-
mediated resistance to AR-targeted therapy (ARi). We observed this in a setting of both ligand-dependent
and ligand-independent GR signaling. Furthermore, preliminary proteomics studies show that GR
phosphorylation is expressed with progression to castrate-resistant PCa (CRPC) and increases
significantly in enzalutamide-resistant CRPC. This increase also correlated with an increase in AKT1
expression. We found that AKT1 is directly bound to GR, which validates the finding by others.
Pharmacologic inhibition specific for AKT1 or knockdown of AKT1 significantly decreased pGR(s134) but
not total GR. In addition, inhibition of AKT1 inhibited pGR(s134) expression in the nucleus with or without
ligand. When cells were exposed to a GR-specific modulator (GRM), CORT134, in combination with
enzalutamide and the presence/absence of ligands, we only observed suppression of cell proliferation in
CRPC but not very effective in enzalutamide-resistant CRPC. Conversely, AKT1 inhibition decreased
pGR(s134) in the nucleus, with/without ligand, and was also associated with inhibition of cell proliferation.
Phospho-site mutation on pGR(s134) was also associated with suppressed cell proliferation. Our central
hypothesis is that induction of oncogenic GR in enzalutamide-resistant CRPC is modulated by PTM on
GR, and inhibition of pGR, would re-sensitize treatment-resistant CRPC to enzalutamide. We will test our
central hypothesis and accomplish the objective of this application by pursuing the following specific aims:
(i) Characterize ligand-dependent driven GR vs. PTM-driven GR expression and activity in patient-
derived xenograft models using multi-omic assays, (ii) Perform functional studies to determine the
mechanism of PTM driven GR vs. ligand-dependent GR activity in lethal PCa (iii) Determine the
therapeutic efficacy and benefit of targeting AKT-GR-AR as a novel therapeutic approach for lethal
prostate cancers. Impact: The results from this study will significantly expand our knowledge of the
mechanism of PTMs in advanced PCa and the role their unique signatures play in disease progression
and resistance to AR and/or GR targeted therapy. Currently, clinical trials are testing the therapeutic
effects of ARi with GRM or ARi with AKT1-specific inhibitors in PCa. Our findings will be of immediate
clinical relevance as they would guide what stage patients with advanced disease would benefit from
GRMs and at what stage alternative approaches (targeting GR PTMs) be used in GR-driven lethal
disease.

Public health relevance
PROJECT NARRATIVE Activating the compensatory signaling pathway for survival is expected in cancers, especially prostate cancer. We have learned that inhibition of AR can induce GR expression and activity to evade AR blockade. Currently, clinical trials are testing the therapeutic effects of AR-targeted therapies with GR modulators (NCT03674814) in CRPC. This proposal will study GR-driven lethal prostate cancers' complexities, mechanisms, and vulnerabilities across advanced disease stages.